Technical and Administrative Management Services in Support of Domestic and International Collaborative Research Efforts

This funding supports core infrastructure to facilitate clinical research on potential Zika, Chikungunya, and Dengue infections in Mexico, and for the development and implementation of informatics technology for the research.